Phase II, Multi-arm, Molecularly-Guided Umbrella Trial for Children and Young Adults with High-Grade Glioma

Project Summary
High-grade gliomas (HGGs), including diffuse intrinsic pontine glioma (DIPG), are a leading cause of cancer-
related death in children, adolescents, and young adults. Despite intensive multimodal therapy, prognosis for
pediatric, adolescent, and young adult patients with these aggressive brain and/or spine tumors remains dismal,
with 5-year overall survival (OS) <10%. Genome-wide sequencing analyses have identified recurrent somatic
alterations of receptor tyrosine kinases, cell cycle regulation, DNA repair, and/or PI3K/AKT/mTOR signaling
pathways within molecularly distinct subgroups of pediatric HGG/DIPG, with therapeutic and prognostic
implications. However, lack of consistent, prospective and comprehensive tumor molecular profiling in pediatric
early phase trials of targeted agents and insufficient assessment of correlative biomarkers of response and
resistance have hampered the interpretation of trials’ results and impeded the rational development of
successive studies. Motivated by this critical need to develop novel, effective, and well-tolerated therapies for
pediatric HGG/DIPG and guided by recent discoveries which have improved understanding of their genomic
landscape, we have developed and recently opened TarGeT, an innovative molecularly-guided, multi-arm,
multi-institutional phase II umbrella trial, with central, comprehensive molecular characterization using
a multi-omic approach (whole exome sequencing, RNA-based fusion panel, DNA methylation array) with
rapid return of results (within 3 weeks) to guide assignment to one of eight biologically-targeted
treatment arms, all with upfront radiotherapy (RT). Efficacy of these targeted therapy arms will be assessed
through evaluation of survival outcomes, compared to molecularly-stratified, historical controls. Furthermore, we
will collect serial, well-annotated biospecimens (peripheral blood, cerebrospinal fluid, tumor tissue), as
well as neuro-imaging to determine multimodal biomarkers predictive of response and resistance.
Longitudinal genomic and immunologic profiling will be performed, and integrated with imaging data for
correlative analyses, focused on (a) validating “liquid biopsy” molecular assays, (b) identifying genetic alterations
which confer the greatest sensitivity to investigated targeted therapies within each arm, and (c) determining
genomic and immunologic signatures that predict radiographic response to RT, including distinguishing between
inflammatory pseudoprogression and true tumor growth. These samples provide an unprecedented opportunity
to systematically characterize and evaluate biological determinants of therapy response. Finally, submission of
serial MRIs at standardized disease evaluation timepoints will allow prospective validation of volumetric
radiographic response assessments using artificial intelligence methodology, comparison to conventional
bidimensional measures, and correlation with outcomes. If feasible and effective, this precision medicine
approach, utilizing genomic, immunologic, and imaging biomarkers validated here may be incorporated into the
treatment of pediatric HGG/DIPG to expand molecularly-guided therapy options and improve outcomes.

Public health relevance
Project Narrative: We propose an innovative multi-arm, multi-institutional umbrella trial offering a precision medicine approach to treat children and young adults newly-diagnosed with high-grade glioma (HGG), including (DIPG), who have historically had limited treatment options and a dismal prognosis. Comprehensive genetic sequencing, performed on patients’ diagnostic tumor tissue with rapid return of results within 3 weeks, will allow assignment of patients to treatment arms, directly targeting genetic alterations identified in their individual tumor. The objectives of the study are to determine treatment efficacy on each arm and analyze serial imaging as well as tumor, blood, and spinal fluid samples to assess whether patients’ genetic and immune make-up are associated with response to targeted therapies.